6th International Conference of Quantitative Genetics

Support is requested for contributing US graduate students and postdocs at the 6th Interna- tional Conference on Quantitative Genetics (ICQG6) to be held in Brisbane, Australia, June 14-19 2020. As with the previous ICQG's, including ICQG5 held in Madison, Wisconsin, the conference will provide a comprehensive survey of the current status of quantitative genetics. Quantitative genetics is the ﬁeld of study that investigates the genetic contribution to variation between indi- viduals in populations, and hence is fundamental to understanding diﬀerences between people in the context of human disease. However, genetic variation underpins variation between individuals in agricultural and model species, and the methodologies of analysis are shared across these disci- plines. New technologies in genomics and molecular genetics of the last decade have propelled novel developments in statistical methodologies. These new technologies are providing both opportunities and challenges for our understanding of the genetic basis of quantitative traits in human and other natural populations, the evolution of characters, and use for plant and animal breeding. ICQG6 is unique in the conference circuit for bringing together researchers addressing similar problems from diﬀerent perspectives, and these interactions can precipitate new research directions.

Public health relevance
The 6th International Conference on Quantitative Genetics (ICQG6) will be held at the Univer- sity of Queensland Australia in 2020, with a major theme of describing eﬀorts to characterize the genetic determinants of health. Most disease traits are quantitative since they are under the control of many genes, and common multifactorial diseases have a massive societal burden with even small changes in incidence, severity and treatments having signiﬁcant impact on health economics and population well-being. New statistical techniques that address complex traits and the integration of genotype, gene expression and clinical trait data will be covered in the Conference.